Leveraging a community-driven approach to address the impact of social determinants of health on structural inequities among Miami-Dade County's intergenerational LGBTQ+ Community

Abstract
A plethora of research exists highlighting the disproportionate disparities faced by sexual and gender
minorities (SGM) of all ages, such as increased levels of homelessness, lack of access to healthcare, and
negative physical and psychological outcomes. While there have been significant efforts to address
systemic racism and social determinants of health (SDOHs) at the community level throughout the US
(such as improving access to safe, affordable housing, improved healthcare, etc.), these efforts tend to
neglect to properly integrate the experiences of SGM. There is also a severe lack of data, particularly
across that lifespan, that examines the intersectionality of sexual orientation, gender identity, and health.
This project addresses how the SDOHs impact structural inequities across the intergenerational SGM
community of Miami-Dade County, FL, and will provide place-based structural interventions and
development of a shared data system to improve health outcomes. Using the NIH Sexual & Gender
Minority Health Disparities Research Framework as a foundation, place-based structural interventions
will be co-designed with the target population and local Health Equity Research Assembly; longitudinal
data will be collected using a mixed-methods approach; and a sustainable shared data system will be
developed, including a data dashboard that includes SGM demographic indicators across all indicators
and improvement to existing data collection tools.
This project aims to produce positive health outcomes across the lifespan and improvements on social
determinants of health impacting MDC's SGM population and a sustainable, replicable model
generalizable not only to SGM populations in other geographic locations, but to other vulnerable
populations.